Creating New Tactile Sensations for Tactile Aids with Designer Materials

PROJECT SUMMARY
For blind people, visual aids like a graphic or a plot are not accessible. Instead, tactile aids are used help render
abstract concepts through an arrangement of physical features, like bumps, lines, and textures. Although useful,
static tactile aids cannot easily render many abstract concepts and still face difficulties when displaying large
amounts of information. A key issue with displaying dense, complex information is that using too many lines or
bumps in a small space creates “tactile clutter”, leading to confusion and misinterpretation by the user. In fact,
the ability of tactile aids to render information by touch is practically at full capacity. While fabrication costs are
lowering with emerging technologies, the core technology of using patterns of bumps and textures to render
information by touch has largely remained the same. Most current research is not focused on addressing this
fundamental limitation and instead sidesteps by using other senses instead, like audio. Therefore, there has
been little progress in tactile stimuli generated by a tactile aid, which has limited their ability to make complex
information accessible for blind people. To address the lack of methods to create tactile sensations in static
tactile aids, this research will increase the variety and density of tactile sensations by using “designer materials”.
Designer materials, unlike physical features like bumps and lines, are surface coatings which use phenomena
from surface chemistry to control adhesion and friction and thereby generate new tactile sensations. By relying
on surface chemistry, it is possible to exert a level of control and spatial resolution not currently possible.
Designer materials will be combined with current physical features to build the next generation of easier-to-read
and more information dense tactile aids. These tactile aids will be demonstrated in a series of everyday activities
with blind subjects. This project combines our team’s expertise in material science, solid mechanics, human
psychophysics, and tactile aid development. Our project is centered around the discovery of new designer
materials, developing next generation tactile aids, and mechanistic studies into the optimal design of tactile aids.
Together, these areas allow us to rapidly iterate new tactile aids, build rationale guidelines for designing
traditional and next generation tactile aids, and provides a much-needed expansion in the toolkit for tactile aid
developers. To maximize impact, all aspects of the project involve close collaboration with members of the blind
community.

Public health relevance
PROJECT NARRATIVE Tactile aids help people with low vision or blindness maintain independence, but tactile aids remain limited in what they can display because most tactile aids transmit information in a similar way: by using a mixture of bumps, lines, or textures. The proposed work will deliver several designer materials which can create a variety of new tactile sensations by using phenomena from materials chemistry. By increasing variety and control, these designer materials will improve the quality of tactile aids and make it easier to display mathematical concepts, play complex board games, and reduce the burden of everyday activities for people with low vision or blindness.